Identifying Microbial, Epithelial and Immune Cell Interactions that Mediate Mucosal Homeostasis and Determine IBD Phenotypes

OVERALL ABSTRACT
Interactions between a genetically susceptible host’s mucosal immune system, epithelial barrier and enteric
microbiota contribute to the pathogenesis of human inflammatory bowel diseases (IBD). Solving the
pathogenesis of IBD and ultimately curing and preventing these chronic, debilitating conditions depend on
innovative use of experimental animal models and translational research in human tissue samples to better
understand functional, mechanistic interactions between mucosal immune regulation, epithelial responses and
enteric microbes that determine intestinal homeostasis vs inflammation. Evidence from human IBD supports
the hypothesis that inflammation results from overly aggressive T cell responses to a subset of intestinal
microbiota in genetically susceptible hosts with defective mucosal barrier function. Our major objectives of this
revised competing renewal are to apply multidisciplinary, mechanistic translational approaches to identify
molecular factors and bacterial species that mediate immunologic and epithelial homeostasis and determine
how loss of these protective mechanisms result in IBD. Our overall two-part hypothesis is: (i) Bidirectional
interactions between intestinal microbial subsets and adaptive (T and B cell) immune and epithelial signaling
pathways maintain mucosal homeostasis and (ii) these immune, epithelial pathways and microbial profiles
predict disease outcomes and identify clinically relevant subsets of IBD patients. Our translational studies
focus on ‘mucosal defense’, involving microbial “crosstalk,” and immune-epithelial interactions. This
Program Project addresses basic and translational aspects of these interactions and how they impact clinical
IBD heterogeneity. We will test our hypotheses through two overarching aims that link four independent yet
intricately integrated projects and two cutting-edge cores.
Aim 1: Establish how normal mucosal immune-microbial interactions promote mucosal homeostasis
and prevent chronic intestinal inflammation.
Aim 2: Use integrative transcriptomics and microbial profiling to molecularly phenotype IBD subsets.
This Program Project capitalizes on interactions among multidisciplinary investigators with extensive expertise
in microbiology, mucosal immunology, metabolomics, genomics, computational biology and clinical IBD. In just
5 years, this integrated group has already improved understanding of mechanisms involved in IBD
pathogenesis using refined experimental disease models and how these pathways impact human IBD.
Renewal allows this group to advance these studies to improve management of IBD patients in an
individualized fashion.
1

Public health relevance
PROJECT NARRATIVE (OVERALL P01) Crohn’s disease and ulcerative colitis, which affect 1.5 million USA citizens, result from aggressive immune responses to subsets of resident intestinal bacteria and epithelial barrier dysfunction in genetically susceptible individuals. A healthy intestine is maintained by beneficial resident bacteria that stimulate regulatory immune cells and secrete metabolites that maintain healthy epithelial cell function and molecular pathways that prevent inflammation. This established group of highly collaborative, interdisciplinary investigators will identify mechanisms by which these protective pathways maintain protective immune and epithelial function and search for novel bacterial and molecular signatures that predict clinical outcomes in Crohn’s disease patients, including progression of disease, development of complications and recurrence after surgical resection.